Development and Validation of a Targeted Transcriptomic Integration (Rat S1500+) for Use with Rat Cellular Lysates

To acquire and test technology for mid to high throughput transcriptomic measurement of gene expression changes in rat cellular lysates after acute chemical exposures (Rat S1500+ validation at Biospyder). Keywords: toxicity, high throughput transcriptomics.